Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Report Preparation

A number of complex scientific reports are prepared under this project by compiling information from Division of Translational Toxicology (DTT) staff, contract laboratory reports, and DTT data tables. Information is compiled and reviewed for internal and external consistency and for scientific accuracy. Reports prepared under this project included NTP Technical Reports on sulfolane, alpha-pinene, and multi-walled carbon nanotubes; NTP Toxicity Reports on phenolic benzotriazoles, boric acid, and Garcinia cambogia extract; NTP Developmental and Reproductive Toxicity (DART) Technical Reports on N-butylbenzenesulfonamide and 2-hydroxy-4-methoxybenzophenone; an NTP Research Report on age-related phenotypes; and NIEHS Reports on 1,2- and 1,4-dichlorobenzene. Keywords: report preparation, toxicology.